TREATMENT OF CHRONIC IDIOPATHIC THROMBOCYTOPENIC PURPURA

These studies are designed to ascertain whether treatment with 2CdA or desferrioxamine will raise platelet counts in patients with refractory ITP, who are at continuous risk of bleeding.